Annual meeting of the American Society for Rickettsiology

The American Society for Rickettsiology (ASR) is the primary society for scientists studying Rickettsiales, obligate intracellular bacteria that are significant cause of morbidity and mortality world-wide. The 33rd Meeting of the AmericanSociety for Rickettsiology (ASR) will be held July 13-16, 2024, in Williamsburg, Virginia, with the 34th meeting to be held in 2026 at a location to be determined. In addition to the 2024 and 2026 meetings, ASR will participate in the 2025 International Conference on Rickettsia and Rickettsial Diseases in Lograno, Spain, by sponsoring an oral session and travel awards for trainees and young investigators. The annual meetings of the ASR aim to 1) provide the highestquality scientific program to attract outstanding researchers in academic, governmental, and private sectors and 2) promote scientific opportunities for trainees and early career investigators to present and discuss their work in a collegial, yet scientifically rigorous environment. The 33rd and 34th meetings will feature a balance of oral presentations from established/junior investigators and trainees, intermingled with posters from submitted abstracts. To increase crossdisciplinary research, oral sessions will feature a Plenary Lecture from an accomplished investigator outside the field of rickettsia. Members of the ASR
Scientific Committee will select oral (short) presentations based on: (i) the quality and originality of the research; and (ii) representation from a wide range of institutions and geographic regions. In all activities, we will provide networking opportunities for students, postdoctoral fellows, and early career investigators to engage with established scientists. Mailings, e-posters, and social media advertisement will highlight the availability of travel awards for attendees. A website will feature the schedule, information and registration materials for the meeting, and ASR will offer optional financial assistance for participants with family care needs. The meeting venue includes on-site childcare options and is accessible to all guests. Approximately two hundred attendees representing early career investigators, mid-career scientists, established researchers, and
clinicians from academia, government, and private-sector laboratories are anticipated to attend. There is no equivalent meeting that focuses exclusively on rickettsial diseases in the United States of America.

Public health relevance
The Annual Meeting of the American Society for Rickettsiology assembles clinicians, researchers, and public health scientists whose interests center on Rickettsia bacteria, a significant cause of human disease, to drive collaborative multidisciplinary research.